Molecular Binding Partners of Non-canonical Ubiquitin Chains

? DESCRIPTION (provided by applicant): Ubiquitin is a small, 76 amino acid proteins that is a post-translational modification (PTM) attached to protein targets. It is central to eukaryotic biology and controls protein degradation, trafficking, and regulation. Problems within the ubiquitin regulatory system can stem from or cause disease. However, unlike other PTMs, ubiquitin can be subsequently modified, creating chains of varying linkage and size that give rise to the wide array of biological effects of target proteins. This complexity is sometimes referred t as the ubiquitin code. The study of poly-Ub chains has historically been hindered by access to these molecules. This proposal capitalizes on recent developments in unnatural amino acid mutagenesis and protein chemistry to synthesize poly-Ubs. The proposed research will i) synthesize and immobilize non-canonical Ub chains, ii) use a proteomics strategy to enrich and identify novel cellular Ub-binding proteins, and iii) use phage display to identify high-affinity ply-Ub binders. These three goals will provide drastically improved understanding of the ubiquitin code and provide research tools to all researchers working in ubiquitin biology.

Public health relevance
PUBLIC HEALTH RELEVANCE: Defects in the ubiquitin-mediated signaling pathways are associated with numerous diseases, including neurodegenerative disorders, cancers, developmental disorders, immune and inflammatory disorders, and muscle wasting. This project will develop chemical tools and methodologies to identify molecular binding partners for a range of polyubiquitin signals that have not been characterized so far. This research will extend our understanding of the molecular mechanisms of recognition and regulation in ubiquitin-mediated signaling pathways and assist in the design of novel inhibitors to control these processes.